Defining a role for the mitochondrial protein sulfite oxidase in nucleolar ribosome biogenesis

PROJECT SUMMARY/ABSTRACT
The mitochondrial protein sulfite oxidase (SUOX) has surprisingly emerged as a potential regulator of ribosome
biogenesis in a genome-wide screen. Ribosome biogenesis, which occurs in the nucleolus of eukaryotic cells,
is a highly regulated process essential for cell function. Despite its importance and relevance to diseases such
as cancer and ribosomopathies, the regulation of ribosome biogenesis in human cells is not fully understood.
To identify novel regulators of this process, the Baserga laboratory pioneered a genome-wide siRNA screen
using the number of nucleoli per nucleus as an endpoint. MCF10A breast epithelial cells have an average
nucleolar number of 2-3, and a decrease to one indicates aberrant ribosome biogenesis. SUOX is a
mitochondrial protein that has unexpectedly surfaced as a hit from this screen. SUOX oxidizes toxic cellular
sulfite to sulfate, and some SUOX variants are known to cause the severe, fatal developmental disease
Isolated Sulfite Oxidase Deficiency (ISOD). Validation shows that SUOX depletion reduces nucleolar number
and ribosomal RNA (rRNA) biogenesis. I have collected further data demonstrating ribosome biogenesis
disruption upon SUOX depletion, and proteomics data strongly supporting a role for SUOX in making
ribosomes. The similarity of the presentation of ISOD to that of known ribosomopathies, along with our
intriguing preliminary results, has raised compelling questions about the involvement of ribosome biogenesis in
ISOD pathogenesis. Drilling down to the mechanistic level, our preliminary metabolomics data reveal that
SUOX depletion causes a decrease in the methyl donor required for the nucleolar methyltransferase fibrillarin.
Fibrillarin methylates an rDNA-specific histone and rRNA, regulating rDNA transcription and rRNA processing,
respectively. To date, no work has investigated the role of SUOX in ribosome biogenesis nor of ribosome
biogenesis in ISOD pathogenesis. In Aim 1, I will establish the precise role of SUOX in ribosome biogenesis,
taking advantage of established assays measuring multiple stages of the process. I will describe effects of
SUOX depletion on rRNA methylation using the recently developed RibOxi-seq method, and histone
methylation using established antibodies. I will further validate our results using the auxin-inducible degron
version 2 (AID2) system. In Aim 2, I will determine the effects of disease-associated SUOX variants on human
ribosome biogenesis by rescuing the defects that occur upon siRNA-mediated SUOX depletion with
translationally silent and disease-associated loss-of-function SUOX variants. The experiments proposed will
clearly define a role for SUOX in human ribosome biogenesis and describe the effects of known disease-
causing variants on this essential cellular process. Our unique approach based on an unbiased screen for
nucleolar function, combined with both well-established and novel methodology to study ribosome biogenesis,
gives us the opportunity to take the field of SUOX research in an entirely new direction that will open avenues
for understanding the function of SUOX in cellular metabolism and human genetic disease.

Public health relevance
PROJECT NARRATIVE In all cells, mRNA is translated into protein by ribosomes, which are made in a process called ribosome biogenesis. The aim of the proposed research is to determine the role of the mitochondrial protein sulfite oxidase, or SUOX, in human ribosome biogenesis. Variants of SUOX cause the severe disease Isolated Sulfite Oxidase Deficiency (ISOD); the research proposed will advance knowledge of ribosome biogenesis regulation and determine the role of ribosome biogenesis in ISOD, contributing to understanding its pathogenesis and treatment.